Mental Health Research Network II

The proposed Administrative Core during the second funding cycle will include: An organizational unit (led by Belinda Operskalski) responsible for: o Communications within MHRN and with external stakeholders and collaborators o Compliance with regulations regarding privacy and human subjects protection o Efficient monitoring and management of MHRN finances An informatics unit (led by Gregory Simon and Christine Stewart) responsible for maintenance of existing MHRN data infrastructure as well as development of new data resources, including: o Empirically validated

Public health relevance
The Administrative Core of the Mental Health Research Network will maintain and improve infrastructure to support population-based mental health research. Components will include: an administrative unit supporting communications, financial management, and compliance; an informatics unit supporting and developing data infrastructure, and an outreach and external collaboration unit.